Probing the role of the IRE1alpha-XBP1 pathway in normal and malignant hematopoiesis

Project Summary Development of blood cell lineages from hematopoietic stem cells (HSC) is stringently regulated, and defects in this process cause diseases including blood cancers like acute myelogenous leukemia (AML), the most lethal leukemia subtype. Faced with dynamic and potentially oncogenic perturbations in their bone marrow microenvironment, how HSC progenitors balance self-renewal with differentiation and preserve their integrity remains a central question in hematopoiesis. The highly conserved endoplasmic reticulum-membrane kinase- endoribonuclease IRE1α (inositol-requiring enzyme-1), acting through the product of its mRNA substrate X-box binding protein (Xbp)-1, orchestrates an “unfolded protein response” program that facilitates ER protein folding in eukaryotic cells. Beyond this role in cellular proteostasis, I recently discovered that the IRE1α/Xbp1 pathway is a critical cell-intrinsic brake against myeloid leukemogenesis in HSCs. In a mouse model of the Flt3 internal tandem duplication of the juxtamembrane region (Flt3-ITD), the most frequent mutation in AML, HSC- specific loss of IRE1α/Xbp1 caused a lethal AML not seen in WT Flt3-ITD mice. Consistent with these findings, we found that downregulation of an IRE1α/Xbp1 target gene signature was associated with poor overall survival in a cohort of AML patients, revealing the novel possibility that dysregulated IRE1α/Xbp1 signaling importantly contributes to AML pathogenesis. Preliminary transcriptome analysis of IRE1α-deficient HSCs revealed a marked upregulation of Wnt/β-catenin signaling, a key pathway required for the development and function of the “so-called” leukemia stem cells (LSCs), few quiescent and self-renewing cells that initiate, maintain and are implicated in AML relapse but are rarely targeted by current therapies. As IRE1α is a convergence point and sensor for various cellular perturbations (e.g. reactive oxygen species, hypoxia, nutrient deprivation, chemicals, cytokines and metabolites), our findings suggest a novel paradigm in which activation of IRE1α in response to these perturbations restrains the self-renewal potential of HSC progenitors to mitigate leukemogenesis. Using mouse AML models integrating IRE1α activity reporter and inducible Xbp1 transgene that I recently developed, we will address how the IRE1α/Xbp1 pathway is regulated during hematopoiesis (Aim1) and the molecular mechanisms by which this pathway suppresses myeloid leukemogenesis (Aim 2). There is increasing appreciation that because of their important role in AML pathogenesis, eradication of LSCs will be critical to achieve long-term AML remission. As IRE1α/Xbp1 suppresses the Wnt/β-catenin signaling required for LSC function, we will test the hypothesis that targeted activation of the IRE1α/Xbp1 pathway in HSC progenitors will limit LSC development and function (Aim 3), providing an innovative strategy for durable AML therapy. These studies are integral to my long-term commitment to run a strong successful independent research laboratory focused on understanding normal and malignant blood cell development with the ultimate goal of discovering improved therapies for blood cancers.

Public health relevance
Project Narrative Understanding the mechanisms that safeguard the integrity of the process of blood cell generation from hematopoietic stem cells (HSCs) is central to our ability to understand and cure diseases like blood cancers including acute myelogenous leukemia (AML), the most common and often aggressive human leukemia. The proposed research will significantly advance knowledge on how HSCs in the bone marrow are protected by a novel activity of the stress response proteins IRE1α/Xbp1 against oncogenic transformations that initiate AML. Building on this function, this study will also seek to establish evidence that targeted activation of the IRE1α/Xbp1 pathway in malignant HSC progenitors and the leukemia stem cells that underlie aggressive AML can be a novel therapeutic option to limit the progression of AML, one of the most lethal blood cancers today.